The Genetic Basis of Morbidity and Mortality in Small for Gestational Age Preterm Infants

PROJECT SUMMARY/ABSTRACT
Preterm infants experience high rates of severe morbidity and mortality prior to discharge home. One of the
leading factors associated with morbidity and mortality is being born small for gestational age (SGA; less than
10th percentile for gestational age and sex). While many etiologic factors have been identified, including
maternal illnesses, infections, and prenatal exposures, these factors explain only a fraction preterm SGA birth.
Some genetic disorders have been shown to cause preterm SGA birth. Genetic disorders have also been
linked to morbidity and mortality in related populations. My prior research and that of others indicates that
genetic disorders likely contribute, but the overall genetic contribution is unknown. In this project, my team and
I will define the prevalence of genetic disorders in this population, the contribution of genetic disorders to
morbidity and mortality, and identify disorders in novel genes associated with preterm SGA birth. Using similar
strategies, I recently determined that congenital renal anomalies are prevalent in preterm infants, and strongly
associated with genetic disorders. Work by my mentors showed that a specific class of genetic variants—loss-
of-function (LoF) variants in novel genes—contribute to related diseases. I hypothesize that common, rare, and
novel genetic disorders contribute to preterm SGA birth, morbidity, and mortality. I will investigate this through
three complementary aims: 1) define epidemiologic factors associated with preterm SGA birth, including
common genetic disorders, 2) determine the prevalence of rare genetic disorders in preterm SGA infants, and
3) identify novel genes associated with preterm SGA birth. Positive results would inform improved diagnosis
and management of this high-risk population and inform new research into molecular pathogenesis. Negative
results would inform research into environmental factors, as well as other genetic diagnostic strategies.
This project is central to my Career Development Plan, which consists of three Training Goals: 1)
epidemiologic research, 2) human genetics research, and 3) academic development. This project will be
mentored by world-class experts in human genetics and perinatal medicine: Drs. Ali Gharavi, Anna Penn, and
Ronald Wapner. And this project will be conducted at one of the premier research institutions, Columbia
University, which supports a regional referral neonatal ICU and the Institute for Genomic Medicine. Aim 1 of
this project will be conducted using a robust database containing records from 409,704 preterm infants. And I
will be supported by expert advisors in epidemiology, statistics, and genomics. Through the completion of this
research and training, I will gain an ideal skillset to become an R01-funded investigator advancing the field of
genomic neonatology.

Public health relevance
PROJECT NARRATIVE Growth restricted preterm infants experience high rates of morbidity and mortality. The prevalence of genetic disorders and contribution to morbidity and mortality are unknown in this population. The purpose of this project is to determine the contribution of genetic disorders to preterm growth restricted birth and to subsequent morbidity and mortality.